PATHOPHYSIOLOGICAL AND HORMONAL REGULATION OF MEMBRANE TRANSPORT SYSTEMS

This report described studies on sodium, proton, potassium, calcium and other ion fluxes in relation to the control of intracellular and extracellular environents, acid-base balance and metabolism; their control by hormones, pathophysiological effectors and pharmacological agents; and how these regulatory systems are affected by age and by age-associated disease. The findings summarize investigations on: 1. Na+-H+ exchange activity decreased in the sensescent rat. 2. Mechanism of the renal response to an acid load in aging. 3. Thyroid hormone regulation of Na+-H+ exchange activity. 4. Biochemical characterization of the Na+-H+ exchange carrier. 5. Parathyroid hormone (PTH) regulation of cytosolic Ca2+ in proximal tubules. 6. Regulation of protein kinase C. 7. Pharmacological studies of the calcium-activated potassium channel in cultured medullary thick ascending limb cells.